Translational Aging Research Training Program

The U.S. population is aging rapidly, with a rising burden of chronic diseases, functional impairments, and cognitive decline among older adults. In parallel, major scientific advances have expanded our understanding of the biological mechanisms underlying aging and have introduced engineering and bioengineering innovations with the potential to extend healthspan, the period of life spent in good health. However, a persistent gap remains in translating these discoveries into real-world interventions that improve clinical outcomes and enhance healthspan for older adults.
To address this translational gap, the Translational Aging Research Training Program was launched in 2018 to develop future leaders in aging research. Despite disruptions due to COVID-19, the program successfully trained 14 fellows from clinical, biological, and engineering, disciplines. This renewal proposes an enhanced program embedded in the interdisciplinary ecosystem of the Johns Hopkins Human Aging Project (HAP), an institutional initiative that foster collaborative research and training to extend the healthspan and improve the lives of older adults.
This program will continue to leverage strong scientific leadership, a rich research infrastructure, and a supportive environment that welcomes individuals from all backgrounds committed to excellence in aging research. Its specific aims are to:
1) Deliver an interdisciplinary training experience in translational aging research for postdoctoral fellows (MD and/or PhD), structured around core coursework, interdisciplinary meetings, weekly translational aging seminars, individualized development plans, and leadership training.
2) Provide each fellow with a mentored research experience in translational aging science, either in biology, engineering, or clinical research.
3) Enable access to a broad network of resources and aging-focused research infrastructure at Johns Hopkins.
4) Prepare trainees for long-term success in academic careers through individualized mentoring and professional development activities.
By the end of the program, trainees will possess:
-Interdisciplinary expertise in aging biology, clinical geriatrics, and engineering approaches to aging-related problems;
-Skills in translational science to move discoveries from bench to bedside;
-Competencies in leadership and collaboration to pursue impactful research careers that aim to extend healthspan and improve aging-related outcomes.

Public health relevance
The population of older adults in the United States is expanding rapidly as is the understanding of the aging biology and engineering. In order to better train scientists to improve the health of older adults, clinical, biological, and engineering disciplines need to be brought together to solve problems and improve health of older adults. The purpose of this training program is to train postdoctoral fellows in translational aging research so that they can go on to become scientists focused on improving the health of older adults.